STRESS AND ASTHMA--AUTONOMIC REACTIVITY, AIRWAY FUNCTION AND SUPEROXIDE RELEASE

This study determines whether individual differences in autonomic reactivities to stressors, in conjunction with altered superoxide production, epinephrine and cortisol levels, would predict differential outcomes in airway function in asthmatic individuals.